Insulin and nutrient actions in the FGR fetal liver

PROJECT SUMMARY
Individuals born with fetal growth restriction (FGR) have dysregulated hepatic glucose production (HGP) as
neonates, and higher rates of hepatic insulin resistance and steatotic liver disease with higher hepatic fibrosis
scores as children and adults. We discovered, using the same sheep models as in the current proposal, that the
FGR fetus has an early activation of HGP and hepatic insulin resistance9, hallmark features of type 2 diabetes
(T2D). We also discovered that fetal hypoxemia (HOX model) recapitulates hepatic insulin resistance. Our
compelling new data demonstrates hepatic collagen deposition, a sign of fibrosis, in FGR and HOX fetal sheep.
Thus, in utero hypoxemia during FGR injures the fetal liver initiating both hepatic insulin resistance and fibrosis.
How hypoxemia produces these effects, and the cell-specific mechanisms remain poorly understood, thus
limiting our ability to prevent fibrotic liver disease and T2D risk in the former FGR individual. The goal of this
renewal is to demonstrate that lactate is more than a metabolic substrate and byproduct of hypoxemia and
exerts regulatory control initiating hepatic insulin resistance and fibrosis in the FGR fetal liver. Lactate is abundant
in normal mammalian fetuses with higher concentrations during FGR and hypoxemia. Our FGR and HOX fetal
sheep also have increased systemic and hepatic lactate (i.e., lactate load). In addition to lactate's role as a
precursor for HGP and oxidative substrate in adults and fetuses, emerging studies in adults and cancer cells
demonstrate that lactate is a metabolite signal and driver of epigenomic regulation. Given these and our recent
data, we propose a mechanism whereby increased lactate production and decreased lactate oxidation increase
“lactate load” and enable lactate to be used for HGP; however, this redirection in lactate flux produces energetic
and redox stress. In support, FGR and HOX fetal livers have JNK-FOXO1 stress kinase activation and oxidative
stress, a major cause of insulin resistance and fibrosis in adults. Moreover, in FGR and HOX fetal sheep, collagen
deposition co-localizes with higher lactate entering hepatic periportal regions. Thus, lactate may activate
periportal hepatic stellate cells into collagen-producing cells. These findings form the premise for our central
hypothesis that increased hepatic lactate load via its metabolic, signaling, and epigenomic effects initiates
insulin resistance in hepatocytes and fibrogenic activation in stellate cells with intrinsic programming. Studies in
Aim 1 will use our FGR fetal sheep model to demonstrate how lactate is metabolized in the normal and FGR
fetal liver. We also will identify novel spatial and cell-specific intrinsic mechanisms to understand how fibrosis
and IR develop in the FGR fetus. We propose that lactate-associated metabolism is largely responsible for these
effects in the FGR liver. In Aims 2 and 3, we will directly test the role of lactate on insulin resistance and fibrosis
by experimentally increasing or decreasing lactate load in fetal sheep. We will also perform in vitro studies using
isolated primary fetal hepatocytes and stellate cells to test mechanisms and discern the direct versus indirect
effects of lactate. Overall, our studies will delineate the physiologic and hepatocellular effects of lactate as a
metabolite and regulatory signal in the fetal liver.

Public health relevance
PROJECT NARRATIVE Individuals born with FGR have increased risk for developing hepatic insulin resistance and fibrosis, both hallmark features of liver metabolic diseases. This project examines how increased lactate in the FGR fetus injures the fetal liver initiating both hepatic insulin resistance and fibrosis. These results will enable interventions to be developed that maximize the benefits yet limit the detrimental effects of lactate to prevent liver metabolic disease in children born with FGR.